Infants' self-generated visual statistics support object and category learning

1 Project Summary
2
3 Human visual object recognition is remarkable in its ability to recognize individual objects in challenging
4 circumstances and to rapidly recognize even novel instances of tens of thousands of everyday categories.
5 Although a great deal is known about these processes at maturity, very little is known about their development
6 especially with respect to common everyday objects and the experiences that support robust object recognition
7 and categorization. This gap is critical because object recognition and categorization support early word
8 learning, physical problem solving, and the later learning of orthographies and mathematical symbols. This
9 research projects focuses on visual object learning in 1 year old toddlers, a developmental period that at the
10 front end of marked advances in visual object recognition and a period in which children with multiple risk factors
11 begin to fall behind the normative developmental trajectory. The approach focuses on the properties of real-
12 world visual experiences that support learning to recognize individual objects in challenging visual contexts and
13 generalizing that learning to same category members. The method uses head-mounted eye-trackers to capture
14 field-of-view images from 100 infants 17 to 22 months of age as they spontaneously interact and play with
15 objects; the supplemental projects adds 40 toddlers to the sample who have small productive vocabularies for
16 their age. These “Late talkers” are at risk for future diagnosis of Developmental Language Delay and also show
17 disruptions in the development of visual object recognition. Through active interactions with objects infants
18 generates their own packets of visual data for learning. Multiple visual properties relevant to object perception
19 will be algorithmically measured and quantified. Toddlers’ recognition of the actively-engaged object and a novel
20 object from the same category will be measured in challenging benchmark contexts including clutter, occlusion,
21 and different views. Category generalization will be measured in a name generalization task. Advanced statistics
22 and machine learning will determine the visual properties of self-generated experiences that support infants
23 object recognition and categorization. The research will provide the first characterization of the natural visual
24 statistics of toddlers’ active interactions with objects and potentially transformative evidence that the
25 developmental foundation for human prowess in visual object categorization lies not in experiences with many
26 different instances of a single category, the standard assumption, but in active visual experiences with individual
27 objects.
28

Public health relevance
Project Narrative The proposed research is relevant to public health because visual object recognition and learning is implicated in broad array of cognitive tasks in early the learning of first words, reading and learning the symbol systems of mathematic; the continued risks of children treated for amblyopia and strabismus in perceptual, cognitive and school achievements and the nexus of disrupted visual learning and lexical development in children with Developmental Language Delay and Autism. Understanding infants self-generated active visual experiences is expected to give rise to new diagnostics and behavioral interventions for at-risk infants. Thus, this proposal is relevant to NIH’s mission that pertains to fostering fundamental discoveries and innovative research strategies as a basis for ultimately protecting child health.